Development and Maintenance of Human and Animal Food Rapid Response Teams (U2F) Massachusetts FPP

Project Summary/Abstract
Through the Maintenance of Human and Animal Food Rapid Response Teams (U2F) Clinical Trials
Not Allowed Grant opportunity, the Massachusetts Department of Public Health, Bureau of
Environmental Health, Food Protection Program (BEH/FPP) will maintain conformance with the
most current version of the Rapid Response Team plan, as well as support coordinated
federal/state/local Human and Animal Food (HAF) emergency response efforts. Continued
conformance with the MFRPS will ensure that Massachusetts’ manufactured food regulatory
program maintains best practices for a high-quality regulatory program to reduce foodborne illness
hazards in plants that manufacture, process, pack, or hold foods. BEH/FPP will continue to regulate
and inspect its 1,700 food manufacturers statewide, including licensed and non-licensed facilities
and firms under shellfish and dairy cooperative program inspections. The RRT will rapidly and
effectively address food emergencies, such as foodborne illness outbreaks, using a system of
incident management, laboratory testing, epidemiologic investigations, traceback and recall
operations, public and internal communications, data sharing, and trainings. The Massachusetts
RRT program will continue to be an active member of the Working Group on Foodborne Illness
Control to support an integrated response capacity. BEH/FPP will continue to support the national
infrastructure with continuing participation in the mentorship program. BEH/FPP will collaborate
closely with federal, state, and local public health partners, industry, and other stakeholders as well
as with agencies and organizations in food/feed manufacturing, distribution, and protection to
support its technical and operational foundation for RRT maintenance. Measures to meet goals and
objectives will be carried out within the framework of the US FDA cooperative agreement. BEH/FPP
is committed, through its participation in this cooperative agreement, to maintain and strengthen
the efficiency and effectiveness of food safety and protection in Massachusetts and beyond.

Public health relevance
Project Narrative Through this cooperative agreement, the Massachusetts Department of Public Health, Bureau of Environmental Health/Food Protection Program will maintain conformance with the most current version of the Manufactured Food Regulatory Program Standards (MFRPS) and will support continuation of its Rapid Response Team’s (RRT) capacity to respond to food/feed incidents. The Massachusetts MFRPS Program will continue to ensure and maintain best public health practices for a high-quality regulatory program to reduce foodborne illness hazards in plants that manufacture, process, pack, or hold foods. The Massachusetts RRT Program will support and facilitate long-term improvements and innovation to the national integrated food safety system by unifying and coordinating federal/state/local human and animal food (HAF) emergency response efforts through the following: strong linkages between epidemiology, laboratory, and environmental health/regulatory programs and staff; implementation of Incident Command System (ICS)/National Incident Management System (NIMS) principles and a Unified Command structure to conduct integrated responses to all-hazards HAF emergencies; and the incorporation of training, data sharing, data analysis, communications, and development of best practices and other resources to support national capacity/capability development.